NUTRIENTS AND GROWTH IN PHENYLKETONURIA

This protocol has not yet begun to admit patients. The biostatisticians were used to assist with study design. The Pediatric Genetics staff trained the GCRC Nutrition Staff on the use of their Dietary Analysis Program which will be used to analyze food records.